Artificial Intelligence Assisted Panoramic Optical Coherence Tomography Angiography for Retinopathy of Prematurity

PROJECT SUMMARY
The long-term goal of this project is to determine whether optical coherence tomography (OCT) and OCT
angiography (OCTA) might lead more accurate and objective diagnosis, earlier intervention, and improved
outcomes in retinopathy of prematurity (ROP). It is well established that due to the subjectivity of the
ophthalmoscopic examination, and systematic bias between examiners, there is significant variation in treatment
of the most severe forms of ROP in the real world. This leads to both under-treatment (and poor outcomes due
to retinal detachment) and over-treatment (exposing neonates to the ocular and systemic risks of treatment).
Roughly 20,000 babies per year develop retinal detachments (RD) due to ROP and there is strong evidence that
most of these are preventable. In adult retinal vascular diseases, most notably diabetic retinopathy, OCT and
OCTA can detect and quantify disease features such as diabetic macular edema and retinal neovascularization
before they are noted clinically, enabling earlier treatment and reducing the risk of blindness from RD. However,
evaluating the use of this technology in neonates requires comprehensive examination of the retina, and the
commercially available handheld OCTs are too slow for ultra-widefield (UWF) OCT and OCTA imaging. In the
last grant period, we have successfully developed several faster and wider FOV handheld OCT prototypes with
advances in both hardware and software, performed more than 2,300 individual eye examinations using UWF-
OCT, and demonstrated for the first time that the stage of ROP can be measured in axial thickness. In this
competitive renewal, we will (1) improve our existing handheld OCT to make it simpler to operate, less dependent
on pupillary dilation, and reduce concerns about infection, (2) extend prior work to develop automated deep
learning biomarkers for zone, stage, and plus disease and (3) evaluate whether OCT-derived biomarkers may
facilitate automated and objective measurement of disease progression, regression, and risk. The specific aims
of this proposal are: (1) Develop non-mydriatic quantitative UWF-OCT/OCTA through innovations in hardware
and software. (2) Develop and validate automated UWF-OCT/OCTA derived biomarkers for ROP diagnosis. (3)
Evaluate the clinical significance of UWF-OCT/OCTA derived biomarkers.

Public health relevance
PROJECT NARRATIVE Optical Coherence Tomography (OCT) and OCT angiography (OCTA) have proven the ability to detect subclinical disease, provide quantitative evaluation of disease progression, and improve outcomes in the leading causes of blindness in adults. Technological and practical limitations have limited the application of this technology in routine use for non-sedated children undergoing routine screening for retinopathy of prematurity (ROP), the leading cause of blindness in children. The proposed project will develop an ultrawide field, non- mydriatic, handheld OCT/OCTA system with improved clinical usability of comprehensive retinal exams with non-sedated neonates and evaluate the clinical utility of OCT/OCTA-derived biomarkers in ROP.